Microphysiological systems to Advance Precision medicine for Alzheimer's Disease and Related Dementias (MAP-AD)

PROJECT ABSTRACT/SUMMARY Administrative and Data Management (ADM) Core
The Administrative and Data Management (ADM) Core will oversee all administrative and scientific functions of
the IU MAP-AD Center. The ADMIN Core will be led by Dr. Jason Meyer with assistance from Co-PIs Dr.
Bruce Lamb and Dr. Donna Wilcock, leveraging input from PIs from the other associated Cores. The ADMIN
Core will also be guided by input and suggestions from an External Advisory Board (EAB) and a Center
Steering Committee (CSC). Based upon previous expertise obtained through ADMIN Cores associated with
MODEL-AD, TREAT-AD, and CLEAR-AD Centers at Indiana University, we propose that the ADM Core of the
IU MAP-AD Center will provide oversight in four key areas: 1) coordinating the activities and interactions of
associated investigators and communication with NIA; 2) establishing benchmarks for success, monitoring
projects/cores for bottlenecks, implementing alternative strategies/tactics to ensure success; 3) providing
effective oversight of data management among the cores of the IU MAP-AD Center as a whole; and 4)
ensuring the effective dissemination of research resources, datasets, and protocols for implementation within
the research community. In the formation of our IU MAP-AD team, we have placed a strong emphasis upon the
integration of this Center with ongoing NIA-supported Centers at IUSM, including the Indiana ADRC, MODEL-
AD, TREAT-AD, and NCRAD, among others. The specific aims of our current application are well-integrated
with the ongoing work of these existing centers, extending the impact of our work in a complimentary manner
to other NIA-funded initiatives. Our group also has a strong track record in open-science initiatives, which will
greatly enable the rapid translation of our results and MPS models for broader use within the scientific
community.